Comparing cell types across mutants and species at single cell resolution

ABSTRACT
Single cell gene expression atlases are now routinely generated for human tissues and entire model
organism embryos and have shed light on the diversity of cell types and regulation of gene expression. While
these wild-type single cell atlases can predict candidate regulatory genes across development for focused
studies, further work is needed to determine the regulatory mechanisms and functional importance of the
observed expression patterns at scale. A key problem is how to identify homologous cells between datasets in
which their expression may be altered, for example data from the same tissue across evolution, or from animals
that have experienced a genetic or pharmacological perturbation. This project will use the widely used model
organism Caenorhabditis elegans to develop and test methods to compare cells across such conditions. Our
focus is on two biological problems. In Aim 1, we will compare expression in single cells between C. elegans and
four other related nematode embryos. These nematode species have nearly identical embryonic lineages to C.
elegans despite substantial sequence divergence (>1 substitution per neutral site), making them an ideal test
case for alignment of single cell datasets across evolution. We will generate large single cell RNA-sequencing
datasets for embryos of each species (C. remanei, C. brenneri, C. briggsae and C. nigoni). We will compare both
automated homology transfer and de novo lineage inference methods to identify cell types in each species. We
will use quantitative imaging approaches (smFISH and live imaging of GFP knock ins) to validate the results of
the single cell experiments. The resulting data will allow us to classify genes and cell types by the conservation
of their gene expression, providing insight into the evolution of cell types. In Aim 2, we will test the role of
conserved regulators in the specification and diversification of the mesodermal “MS” lineage (which produces
pharynx, body wall muscle, and some specialized mesodermal cell types). We will measure gene expression by
scRNA-seq after conditional loss of these mesodermal regulators using an auxin degron approach. As in Aim 1,
we will test and validate automated alignment methods for these datasets to identify cells. The resulting data will
allow us to distinguish homeotic fate transformations from the formation of novel cell states, to distinguish likely
direct or context specific targets from indirect targets of each regulator, and to generate a genome-wide
mesodermal regulatory network of a developing animal embryo.

Public health relevance
Narrative While genes are important, an equally important part of our genome is the sequence between genes that controls which genes are switched on or off in each cell of our body, and defects in these “genetic switches” are a major cause of common diseases such as diabetes and cancer. Revolutionary “single cell” methods are allowing scientists to study these genetic switches in thousands of single cells at once, and may lead to the identification of previously unknown types of cells, and to differences between people in the activity of their genetic switches. In this project, we will use a nematode worm as a simple genetic model on which these single cell methods can be improved and comprehensively tested, and get closer to understanding how different cell types arise.